Core 1: Human Subjects Core

The Human Subjects Core B, physically located at the New York Blood Center, will have a centralized function
of 1) optimizing collection of high-quality biologic specimens and clinical data to support the proposed studies in
the four projects described in this PPG renewal application, and 2) providing clinically based insights and analysis
to the laboratory-based investigators on their research projects. The Core will continue to be the primary contact
with the institutional co-investigators to maximize the work efficiency. The aims of the Core include to ensure the
timely and proper collection, transport, distribution, storage, and tracking of high-quality research samples
through use of an centralized cloud-based database and weekly meetings with the clinical and lab investigators
(Aim1); to establish and actively maintain the centralized database of high-quality human subject clinical
information to ensure timely and accurate correlation and annotation of clinical variables to laboratory analyses
(Aim 2) and to provide clinical expertise and insight in both benign hematology and transfusion medicine to the
laboratory-based investigators on their research projects and laboratory data interpretation (Aim 3). Provision
of such critical clinical material together with the clinical expertise of the Core will facilitate and enhance the
clinical applicability of the findings emerging from this Program Project.

Public health relevance
The objective of the Human Subjects Core B is to collect and distribute high-quality biologic specimens and clinical data to the investigative team as well as provide clinical expertise and insight to enhance the clinical applicability of the findings emerging from this Program Project.